Engineering Next-Generation Nanoparticles One Layer at a Time

Project Summary/Abstract
Cancer treatment currently relies on surgery, radiation, and systemic chemotherapy. While these techniques
have greatly improved cancer therapy, they also risk damaging healthy tissue and have incomplete elimination
of the cancer. The use of nanoparticles (NPs) as drug delivery vehicles may reduce these issues by specifically
accumulating in tumor tissue. Further NPs can improve the bioavailability of drugs, widening the range of
potential therapeutics for cancer treatment. Although there have been some successes in the NP field that led
to clinically approved formulations, most have relied on passive means of accumulation and depend on surface
conjugation with polyethylene glycol (PEG) chains. Unfortunately, passive accumulation may not benefit some
cancer types and recent wide-spread use of PEG in commercial products has led to prevalence of anti-PEG
antibodies in the population which risk reducing efficacy of PEG-based therapeutics. Accordingly, there is a great
need to engineer next-generation NPs with improved properties for cancer treatment without the use of PEG.
One promising NP system for cancer drug delivery is layer-by-layer (LbL) NPs which have shown great promise
in preclinical models of cancer as a delivery vehicle for small molecules, nucleic acids or macromolecules. LbL
consists of a simple assembly method involving the alternating adsorption of polymeric species from water onto
a substrate which can be mediated by electrostatics, hydrogen-bonding or other molecular interactions. This
process allows for facile surface modification of NPs which has been shown to enable cancer cell targeting and
to control subcellular localization. However, there is a dearth of knowledge on how to monitor and control the
disassembly of the LbL structure to improve the NP stability and enable precise spatiotemporal control of drug
delivery via LbL-NPs. During the F99 phase, I will explore how to modulate the layer architecture in layer-by-
layer (LbL) NPs. In this project, the effects of solution conditions during layering and other key layer
characteristics will be investigated. Particles will be loaded with interleukin-12, a potent immunostimulatory
protein, to evaluate treatment efficacy of optimized formulations in vitro and in an in vivo metastatic ovarian
cancer model. During the K00 phase, the focus will transition from systemic stability towards characterization of
cellular uptake and intracellular disassembly targeted at gene therapy for cancer treatment. Gene therapy has
had many new exciting breakthroughs in the last decades, but its use in cancer treatment has been limited due
to poor targeting and low transfection efficacy. I will design a library of NP formulations and characterize their
uptake and intracellular disassembly in vitro and in vivo to determine key NP properties that can modulate gene
therapy efficacy. Further, I will design and optimize nucleic acid combinations of new immunotherapeutic
constructs to deliver via the optimized gene therapy formulations.

Public health relevance
Project Narrative Nanoparticles are promising delivery vehicles to improve efficacy and reduce toxicity of cancer therapeutics, but many formulations rely on passive means for tumor accumulation which reduces their therapeutic potential. During the F99 phase, this research project will develop tools to spatiotemporally control the layer structure of liposomal layer-by-layer nanoparticles to generate targeted next-generation nanoparticles for improved immunotherapy of cancer. The K00 phase will continue developing next-generation nanoparticles by synthesizing a library of nanoparticle formulations and characterizing their mechanism of disassembly in vitro and in vivo to design optimal constructs for immunostimulatory cancer gene therapy.